Development of a closed-loop control system for plasma medicine

Project Summary
Plasma medicine is a promising, relatively new field that encompasses the discovery and development of
biomedical applications for cold plasma (a.k.a. non-thermal, non-equilibrium, or atmospheric plasma). Cold
plasma is generated in several forms by using a strong electromagnetic field to ionize gas at atmospheric
pressure and ambient temperature. When cold plasma is applied to living cells or tissues, the effects can range
from subtle changes in cellular metabolism and function to programmed or necrotic cell death, dependent on
plasma properties (or amount of plasma). In therapeutic strategies involving plasma, the dose delivered is an
important determinant of a successful treatment. A sub-optimal plasma dose may be ineffective, while a plasma
dose in excess of that required to achieve the desired outcome may cause adverse side effects. However, no
real-time measure of an effective plasma dose exists. The determination and controlled delivery of a plasma
dose, at present, relies on empirical measures of outcome that assess secondary or tertiary effects of plasma
hours to days after the exposure. There is a critical need for regulation of cold plasma delivery that uses
concurrent measurement of primary plasma effectors (markers) that correlate with biological and clinical
outcomes (endpoints) necessary to define plasma dose. The objective of this grant is to develop endpoint
detection strategies for plasma-based therapies, using plasma-facilitated wound repair as the endpoint and
oxidation-reduction potential (ORP) as the primary detectable marker. The hypothesis is that there is a link
between the absolute ORP and cellular responses, allowing us to develop an ORP sensor-based method that
monitors the plasma dose and feeds this information in a closed-loop control system. The proposed research is
innovative because it will use ORP detection as the basis for a sensor-controlled, closed-loop feedback control
system that will regulate plasma delivery as determined by the endpoint outcome. Collaborative investigational
and development efforts will combine experience in models of in vivo wound healing (Rutgers University), in vitro
models of epithelial wound repair, and plasma biology (Drexel University) with expertise in device engineering
and plasma chemistry (North Carolina State University). The proposed research is framed around the following
specific aims: (1) Establish correlations between CAP dose ranges, measurable biological parameters and
wound healing outcomes using in vivo and in vitro models of wound healing; (2) correlate sensor outputs with
cellular responses in the in vitro scratch assay; (3) develop a closed-loop control system for regulated plasma
delivery; and (4) challenge and optimize the controller in vitro and in vivo. Our focus on endpoint detection and
feedback control for wound healing will facilitate developmental efforts for this particular therapeutic use of
plasma, but will also provide a solid foundation for applying endpoint detection to other translational applications
of cold plasma, including therapies for dermatological conditions, cancer, and infections by viral and bacterial
pathogens.

Public health relevance
Project Narrative This project addresses the crucial need for regulated delivery of cold medical plasma, based on real-time measurements, to reliably and reproducibly deliver plasma components that promote wound healing. We will develop a control system into which commercial sensors will be incorporated to detect when the effective dose of plasma has been applied to a wound. The system will be integrated into two different medical plasma devices and tested for automated control of plasma dose in a murine skin wound healing model.